Regulation of dental pulp stem cell fate

SUMMARY/ABSTRACT
The Problem: The long-term outcome of tissues regenerated with stem cell-based therapies requires functional
vascularization and enervation and a microenvironment that is supportive of the maintenance of undifferentiated
stem cells. In the 1st funding cycle of this project, we demonstrated that neural crest-derived dental pulp stem
cells (DPSC) can differentiate into vascular endothelial cells. In the 2nd cycle, we showed that DPSC-derived
vessels mature upon investment by mural cells and anastomize with host vasculature to become fully functional
blood vessels. During these studies, we observed that a sub-population of DPSCs functions as neural progenitor
cells and differentiate into neural cells while other DPSCs remain undifferentiated via stem cell self-renewal.
Collectively, these tightly modulated events enable the generation of neurovascular stem cell niches in tissues
regenerated with DPSC. However, mechanisms underpinning the generation and maintenance of these niches
are unclear. Therefore, our ability to engage the full potential of DPSCs in tissue regeneration is limited. Premise:
It is known that Brain-Derived Neurotrophic Factor (BDNF) is critical for neurogenic differentiation of progenitor
cells in the central nervous system (CNS) during embryonic development. In contrast, N-Cadherin was shown
to maintain neural progenitor cells in an undifferentiated state in the CNS. Here, we will determine what is the
role of these two signaling pathways in the balance between self-renewal (i.e. maintenance of stemness) and
neurogenic differentiation of neural progenitor cells in the peripheral nervous system using DPSC as a prototypic
mesenchymal stem cell (MSC) population. Further, using single cell RNA sequencing we found that untreated
DPSCs are heterogeneous exhibiting 8 unique cell clusters. Here, we propose studies to understand how DPSC
heterogeneity and plasticity impacts the generation and maintenance of neurovascular stem cell niches in the
pulp. Our overall hypothesis is: “a balance between BDNF-induced neurogenic differentiation and N-Cadherin-
induced self-renewal of neural progenitor cells enables the generation and maintenance of DPSC-derived
neurovascular stem cell niches”. To test this hypothesis, we propose 3 specific aims: S.A.#1: To define the role
of autocrine BDNF on the neurogenic differentiation of DPSC; S.A.#2: To define the role of N-Cadherin signaling
on the maintenance of neural progenitor cells in DPSC-derived neurovascular stem cell niches; S.A.#3: To define
the function of DPSC heterogeneity and plasticity on the generation and maintenance of neurovascular stem cell
niches. Significance: Successful completion of this work will unveil mechanisms that orchestrate the generation
of neurovascular stem cell niches. These niches create a microenvironment that supports the maintenance of
undifferentiated stem cells that can be activated for replacement of dead terminally differentiated cells (e.g.
odontoblasts, neural cells). Understanding processes underpinning the formation and maintenance of
neurovascular stem cell niches will enable novel mechanism-based regenerative therapies and inspire new
approaches to enhance the long-term outcome of tissues regenerated with dental pulp stem cells.

Public health relevance
PROJECT NARRATIVE A critical step towards a broader use of mesenchymal stem cells in therapeutic tissue regeneration is to optimize approaches to maintain stem cell pools that enable healing and replacement of dead terminally differentiated cells in these new tissues or organs. This project is centered on the study of mechanisms regulating the generation and maintenance of neurovascular stem cell niches when dental pulp stem cells are used for tissue regeneration. Optimized approaches that support the function of these specialized stem cell niches will contribute to improving the long-term outcomes of stem cell-based therapies for tissue regeneration.